Psychological and socio-contextual factors in gun carrying and firearm violence

? DESCRIPTION (provided by applicant): Murder is the second leading cause of death among young males in the US, with most of these killings resulting from gun violence in urban minority communities. Policy and behavioral interventions to address this problem have been largely ineffective. Existing research on this issue has been almost exclusively cross- sectional, meaning that many of the factors linked to gun carrying and use (i.e., as part of an antisocial lifestyle, for self-protection, or as a product of social influence) may or may not be influential.A 2013 Presidential Memorandum provided an opportunity to conduct NIH-funded research on the causes and consequences of gun violence in urban males (PA-13-363); research previously banned by Congress. This is a response to that call for innovative research to address this issue. Longitudinal studies would provide more valid information than currently available about the purported factors related to gun carrying and use. These would, however, be lengthy and costly. The proposed project uses two of the most comprehensive longitudinal studies of males ever conducted to examine the mechanisms related to gun carrying and use in urban males from adolescence to young adulthood. Complementary analyses, using comparable measures, will be conducted with a high-risk community sample (i.e., Pittsburgh Youth Study; N=1,009) and a sample of serious juvenile offenders (i.e., Pathways to Desistance study; N=1,107). Together, these studies have information on gun carrying/use as well as theoretically relevant factors related to these behaviors (e.g., drug dealing, victimization) measured at least annually from ~ages 10 to 25. Both have a substantial proportion of youth who have carried guns and shot at others. This is a unique opportunity to do theoretically, programmatically, and policy relevant research on a pressing social problem. Applying state-of-the-art longitudinal approaches, this study will a) use intra-individual analyses to delineate the inter-related effects between individual psychological and socio-contextual variables across development, focusing on factors implicated in the current theoretical formulations regarding gun carrying and use (e.g., psychopathy, gang membership), b) examine the bidirectional effects (i.e., variables as both a cause and a consequence) of gun carrying/use and victimization and attitudes toward violence, c) identify the factors related to the transition from gun carrying to gun use, and d) examine whether certain factors (e.g., drug dealing) are more influential for gun carrying/use among minority vs. White males and whether any racial/ethnic differences are attributable to a disproportionate exposure to specific risk factors (e.g., neighborhood crime). This proposed project is a unique, cost effective opportunity to move research on gun violence forward substantially. It enriches theory about the processes of gun carrying/use, and informs interventions to make them more effective. It will identify what specific risk factors should be targeted, to whom certain types of interventions are most relevant, and the developmental point when specific interventions are most salient.

Public health relevance
PUBLIC HEALTH RELEVANCE: Although homicide is a leading cause of death among young males in the United States, with a majority involving gun violence in urban minority communities, we still know little about how to reduce these killings. This study uses two existing, rich, longitudinal data sets to examine the individual and social-contextual factors related to gun carrying and use during adolescence and young adulthood in males. By applying more exacting, within-individual analytic approaches than previous research, this study will better identify what factors should be the targets of interventions, who should receive these interventions, and at what developmental point specific interventions should matter.